Core D: Special Populations

PROJECT SUMMARY
CORE D-Community Engaged Research (formerly called Special Populations)

The goal of this Phase 2 COBRE is to continue to support research related to opioid use disorder and overdose, and to develop early-stage investigators to conduct research in this high priority area. The proposed Community Engaged Research Core (CERC), formerly the Special Populations Core in Phase 1 of the COBRE, has changed its name to accurately reflect the current activities and future directions of the Core. The Core will continue to promote research among people who are impacted by opioids and overdose and will continue to support the overall mission of the COBRE by building research infrastructure and providing services to early-stage investigators to support the recruitment and retention of individuals from a range of contexts as research participants. However, the focus of the Core has expanded to emphasize the importance of community engagement with the goal of developing more robust, rigorous, and competitive research projects and grants. The focus on community engagement is imperative to provide investigators with the skills necessary to succeed in a global research environment that is prioritizing both community engagement and inclusion of people with lived experience in the area of study. Guided by the conceptual and theoretical framework of Community Engaged and Participatory Research (CEPR), the CERC will focus on addressing these challenges by supporting and expanding community-engaged research. The near-term goals of the CERC are to support project leaders and pilot-funded investigators in the conduct of community-engaged research related to opioids and overdose. The long-term goals of the CERC are to build a sustainable research infrastructure to support research involving people impacted by opioids and overdose across Rhode Island Hospital and affiliated institutions.